Dynamics of Multisensory Cue Integration

Project Summary
To optimally estimate properties of the environment, one should use all available sensory and prior infor-
mation. Sensory input arises from multiple sensory modalities, and is uncertain due to physical and neural
noise. An ideal observer must combine all cues, taking into account cue reliability and considering alternative
causes for discrepancies between cues such as inferring that they derive from different objects (i.e., separate
causes) or that one or both sense modalities are miscalibrated. Human behavior is often consistent with “opti-
mal” cue integration defined as maximizing combined-cue reliability. Can observers access internal estimates
of reliability for confidence judgments to inform subsequent behavior? What computations does the brain use
to solve these problems and how do they unfold over time?
We tackle these questions by combining computational theory and behavioral experiments to elucidate the
dynamics and time course of multisensory cue integration. The standard framework for understanding sensory
integration incorporates five key components: (1) reliability-based cue weighting, (2) integration of prior infor-
mation, (3) causal inference, (4) cross-modal recalibration and (5) confidence in the sensory estimates. Past
work on multisensory cue integration has primarily dealt with situations that are static, but the world is dynamic
and ever-changing, many activities (locomotion, driving, sports, etc.) depend critically on combining information
over time and on temporal estimates, and sensory cue integration unfolds over time. In Aim 1, we will develop
and test models of multisensory temporal perception, both for relative timing and perception of duration as well
as understanding how spatial and temporal correlation jointly contribute to causal inference. In Aim 2 we look
at sensory-motor integration from a similar perspective: the planning and execution of movement also involves
multisensory integration prior to, during, and after a movement, both for movement itself and for judgments
about movement success. Finally, in Aim 3 we look at the use of multiple visual and other sensory cues for
perception of heading and object motion from optic flow and other cues. We will study whether the five compo-
nents of multisensory integration help us to better understand the analysis of optic flow over time, and integrat-
ing optic flow with natural self-motion in a virtual environment, for the estimation of heading and detection of
moving objects.
These studies will shed light on the dynamic processes used to combine sensory information to form a co-
herent percept, the unfolding of sensory integration as perceptual decisions are made, and how our senses
guide us in an ever-changing world. A better understanding of the dynamics of these processes will inform fu-
ture studies on the neural implementation of these computations. These experiments on healthy humans will
provide a starting point for understanding multisensory perception in individuals in which these systems are
compromised by conditions that impact sensory input (e.g., amblyopia, macular degeneration, stroke).

Public health relevance
Project Narrative The proposed work benefits public health by systematically assessing the dynamics of the computations un- derlying perceptual decisions using multiple sensory systems and how decisions take into account the uncer- tainty of sensory information, prior knowledge, and changes over time in the environment as well as in the sen- sory systems themselves. A variety of medical conditions can impact both the reliability and accuracy of senso- ry information (e.g., macular degeneration, amblyopia, stroke). The proposed research will improve our under- standing of how sensory inputs from multiple modalities are combined so as to optimize a perceptual decision or a motor plan, and thus can serve to help in the design of rehabilitative plans and sensory-substitution de- vices when sensory input is disrupted (change in bias, gain and/or variability) by disease or other health-relat- ed conditions.